Dissemination Core

INFORMATION DISSEMINATION CORE ABSTRACT
Health research benefits patients and communities only if scientists and health professionals can find effective
ways to communicate new findings across community and clinical settings. The strategies of the Information
Dissemination Core of the Native Center for Alcohol Research and Education (NCARE) reflect our commitment
to using both innovative and traditional channels to disseminate information and interventions on alcohol use
disorders (AUDs) to American Indian and Alaska Native (AI/AN) communities. Our collaborations with community
and institutional partners, along with more than 20 years of engagement and research in Native communities,
significantly enhance our ability to disseminate new knowledge and new approaches to managing and
eliminating AUDs. This Core will examine how health information is consumed in Native communities, including
those in geographically isolated areas, and pilot-test new ways to disseminate health information and research
findings. Our overarching goal is to facilitate the exchange of beneficial knowledge, practices, and ideas relevant
to AUDs, and to broaden their uptake by local, regional, and national tribal partners and academic stakeholders.
NCARE will be housed within Partnerships for Native Health, a research program at Washington State University.
We will also work closely with NCARE investigators at the University of Colorado Denver and the University of
Washington to disseminate our research on AUDs and related health inequities. Our Specific Aims are to: 1)
Disseminate the results of NCARE Research Projects and Pilot Projects to AI/AN communities by using
innovative, culturally-congruent strategies that will contribute to building new community capacity for prevention
and treatment. Dissemination efforts will be tailored to specific community audiences: healthcare providers,
policy-makers, and lay people; 2) Disseminate the results of NCARE research to the scientific community to
encourage new research collaborations between AI/AN communities and researchers; 3) Conduct needs
assessments in partnership with AI/AN communities to identify local AUD priorities, and then connect interested
communities with NCARE researchers who can provide education and technical assistance that address those
priorities; and 4) Disseminate information to educational institutions, the media, and the public on NCARE’s work
and on externally-sponsored activities pertinent to NCARE’s goals, including training, education, funding, and
technical support. Effective health communication must provide accurate information on AUDs; help people
make informed choices regarding significant health risks; update providers on best practices regarding AUDs in
AI/ANs; help providers become better communicators; and use proven strategies to disseminate research results
on AUDs to Native people and to researchers equipped to partner with communities to address their most
pressing needs.